Maternal Immune Responsiveness As CLinical Target for Preterm Birth Prevention (MIRACL)

Project Summary/Abstract Not applicable for supplement application

Public health relevance
Narrative Not applicable for supplement application